Predictors and Biomarkers for VCID versus Cognitive Recovery after Stroke Thrombectomy in Rural Appalachia

Vascular cognitive impairment and dementia (VCID) is present in 25-30% of stroke patients, and it is difficult to
predict at the time of stroke who those patients will be. The National Plan to Address Alzheimer’s Disease and
the NHLBI-NINDS VCID Workshop called for increased research on VCID prediction, especially in underserved
populations. The proposed research will identify predictors of cognitive recovery in rural, underserved patients
after mechanical thrombectomy for emergent large vessel occlusion (ELVO) stroke. These predictors will target
patients that would benefit from intensive rehabilitation. Our novel biologic sample registry was used to identify
proteins in systemic blood samples taken during thrombectomy as independent predictors of cognitive
performance at post-stroke discharge and 90-day follow-up. The hypothesis is that these proteins will provide
incremental predictive validity for cognitive impairment including dementia, over and above clinical
characteristics, social determinants of health, and traditional ADRD plasma biomarkers. The proposed study will
prospectively enroll 225 patients collecting systemic arterial blood at the time of thrombectomy and analyze
protein expression. Using a retention strategy tailored to underserved rural participants, neurocognitive test data
and venous blood samples for longitudinal protein expression will be collected from 3 months to 2 years post-
thrombectomy. The study site, located in the US Stroke Belt with some of the most medically underserved rural
counties in the nation, will contribute to the NIH priority focus on health disparities. Specific Aim 1: Test the
hypothesis that increased patient home county rurality predicts worse cognitive outcomes post-stroke,
both acutely and chronically. Generalized estimating equation models will test the main effect of home county
rurality and other social determinants of health on cognitive status (normal, cognitive impairment no dementia,
dementia), the main effect of time on cognitive performance across time points, and the interaction of rurality and
time on cognitive status across time points. Associations among rurality, comorbidities, and time-of-thrombectomy
blood protein expression will be auxiliary analyses. Specific Aim 2: Test the hypothesis that ADRD
biomarkers in systemic blood at time of thrombectomy are biomarkers for acute post-stroke cognitive
impairment and chronic VCID two years later. Blood samples will be assessed for known proteomic
biomarkers for cognition at the UKY Biomarker Center. Specific Aim 3: Test the hypothesis that novel
biomarkers in systemic blood at time of thrombectomy predict chronic VCID including dementia, over
and above the effects of ADRD markers. Proteomic analysis will be conducted on time-of-thrombectomy blood
samples to measure the expression of inflammatory-related proteins. Hierarchical generalized estimating
equation models will assess the incremental improvement in prediction of cognitive status over time added by
these addition markers. Analyses will use LASSO methods and split-sample cross-validation to create a
predictive model based on both ADRD and novel biomarkers that predict cognitive outcomes.

Public health relevance
Thrombectomy is a life-saving procedure that removes clot from the brain during stroke, but it is difficult to predict which patients will recover cognitively and which will have persistent cognitive impairment or decline (VCID: vascular contributions to cognitive impairment and dementia)—and it is particularly difficult to predict these outcomes in rural, underserved patients, who tend to have more complicated medical histories and barriers to care. Using a retention strategy tailored to the needs of rural, underserved participants, the proposed study will test how well certain proteins in blood collected at the time of thrombectomy predict the long-term cognitive outcomes of stroke patients in one of the most rural and medically underserved regions in the U.S. Stroke Belt. Study success would address a major rural-urban health disparity and also benefit stroke patients at large by making available the first long-term cognitive profiles of thrombectomy patients, by improving the assignment to proper care using the earliest possible blood markers for VCID versus cognitive recovery, and by opening the door to development of new therapeutics based on blood protein signaling pathways that affect cognitive outcomes.